UCLA SPORE in Brain Cancer

The objectives of the UCLA SPORE in Brain Cancer are to contribute significantly to progress in the diagnosis, prognosis, and treatment of brain cancer. These goals will be accomplished through multiple and varied research projects involving mechanistic pre-clinical work and innovative clinical studies, with a particular focus on developing novel strategies to overcome the problem of treatment-induced resistance. The broad, long-term objectives and aims of our brain cancer SPORE are as follows: 1) to investigate mechanisms of immunotherapy-induced immune evasion following active immunotherapy, and develop rational combinations of immunotherapeutic strategies to overcome the immunosuppressive milieu of the brain tumor microenvironment; 2) to elucidate the alterations in cellular metabolism associated with drug- induced resistance to apoptosis, and exploit targeting apoptotic blocks to induce intrinsic tumor cell death; and 3) to explore the concept of simultaneously targeting both tumor and tumor microenvironment with multi-pronged CAR-T cell therapy as a way to augment therapeutic response and reduce the potential for tumor microenvironment-induced treatment resistance. In order to achieve these translational research goals of our program, we propose three main projects involving: 1) targeting immunotherapy-induced resistance with DC vaccination and PD-1/CSF-1R inhibition; 2) overcoming drug-induced resistance to intrinsic apoptosis in glioblastoma; and 3) targeting glioblastoma cells and tumor microenvironment with CAR-T cell therapy. These translational research projects will be supported by four shared resource cores in administration, biospecimen/pathology, neuroimaging, and biostatistics/bioinformatics. Our program has also been successful in actively incorporating researchers in our Developmental Research and Career Enhancement Programs in order to foster new approaches for assessing and treating brain cancer. Our array of novel SPORE projects and state-of-the-art cores has already made a significant impact on brain cancer research during the last funding cycle, and we hope to continue to make impactful contributions to the field well into the future. Each project has been developed jointly by teams of basic and clinical researchers, with the thoughtful advisement of our internal advisory board (IAB) and external advisory board (EAB), working together in a trans-disciplinary manner to address the most vexing problem in brain cancer – the development of treatment resistance. All three proposed projects are highly translational and will reach new human endpoints within the context of our next SPORE grant period.

Public health relevance
The UCLA Brain Cancer SPORE will support research into new and innovative strategies to diagnose and treat brain cancer, particularly focusing on innovative ways to overcome the problem of treatment-induced resistance to current therapies (i.e., active immunotherapy, chemo/drug therapy, and CAR-T adoptive cell therapy). Despite many different treatment approaches, the five-year survival rate for glioblastoma (WHO grade IV) patients remains dismal, and there are still no definitive cures for this disease. Thus, the proposed research is of relevance to public health, as there is clearly an unmet need for patients with this type of cancer and continued investigations into novel therapeutic approaches for brain cancer are desperately needed.